Elucidating the role of MeCP2 in the pathophysiology of obesity

Project summary
Obesity is a severely debilitating disease state that afflicts 650 million people worldwide. The increased
prevalence of obesity is associated with a number of other diseases such as diabetes, cardiovascular disease,
and hypertension. Given its implications for health care, it is now considered a global epidemic by the World
Health Organization. These alarming statistics call for a need to understand neurobiological mechanisms that
underlie the development of obesity. The goal of the current proposal is to understand the role that methyl-
CpG-binding protein 2 (MeCP2) plays in the etiology of obesity. Recent studies implicate a role of this
neuroepigenetic regulator in precipitating obesity in mouse models and in children diagnosed with Prader-Willi
Syndrome, a neurodevelopmental disorder characterized by hyperphagia and marked obesity. The current
proposal will utilize transgenic mouse models in which Mecp2 is knocked out in order to understand the
neurobiological consequences of Cre-lox mediated knock out of this epigenetic factor in hypothalamic pro-
opiomelanocortin (POMC) neurons. Another goal of this proposal is to understand how POMC-specific
knockout of Mecp2 can alter behavioral responses to food. The data from this proposal will elucidate the role
that MeCP2 plays on the development of obesity and may ultimately lead to therapeutic strategies with which
to combat the obesity epidemic.

Public health relevance
Project Narrative The current proposal seeks to determine if neuroepigenetic mechanisms are involved in the pathophysiology of obesity. The aims of this proposal will be addressed using a recently developed animal model of obesity and will combine molecular biology and behavioral techniques. The results generated from this research will yield significant insight into putative molecular mechanisms involved in the etiology of obesity and will provide potential therapeutic targets with which to treat those individuals suffering from obesity.